REDUCING HEALTH DISPARITIES FOR PEOPLE WITH DISABILITIES CHALLENGE

The National Institutes of Health (NIH) and the Administration for Community Living (ACL) are working to reduce health disparities experienced by people with disabilities. In September 2023, NIH oﬃcially designated people with disabilities as a health disparities population, which both drew attention to the topic and opened funding opportunities for academic research. NIH is addressing health disparities caused by ableism (the belief that people with disabilities are inferior or inadequate leading to discrimination and social prejudice) in healthcare and clinical research through a variety of traditional academic research projects. This prize competition seeks to complement these eﬀorts by engaging with and directly supporting initiatives to improve health equity for disabled people conducted by community groups.
The competition is sponsored by the NIH, NICHD and NIDILRR. The NICHD will be the Servicing Agency and responsible party. Additional NIH partners include the NEI, the NIDCD, the Division of Program Coordination, Planning and Strategic Initiatives (DPCPSI) within the NIH Office of the Director, and the NIAMS.